Mechanisms of increased susceptibility to pulmonary Nontuberculous Mycobacterial disease in the elderly

SUMMARY
Mycobacterium avium (MAC) and other non-tuberculous mycobacteria (NTM) can cause chronic, insidious and
often debilitating lung disease necessitating complicated and extensive multi-drug antibiotic therapy that can be
life-long. Additionally, 50% of treated patients who have culture conversion to negative will suffer a relapse of
either their existing infection or a new infection. While NTM are ubiquitous in the environment and human
exposure throughout life is frequent, pulmonary disease is found almost exclusively among the elderly. It is
therefore not surprising that pulmonary NTM disease is increasing in incidence and prevalence, mirroring
changes in the overall age structure of the U.S. Mechanisms underlying the increased susceptibility to NTM
disease with age are not well understood. Consequently, there is an unmet need in virtually all aspects of this
disease and its management, including an understanding of disease pathogenesis. Adding urgency to this
research area is the fact that the U.S. Census Bureau estimates that by 2030, more than 20% of the US residents
are projected to be at least 65 years old and over. In this application, we propose to test the central hypothesis
that aged individuals are more susceptible to NTM disease due to defects in Th1 T cell immunity coupled
with dysregulation in lung microbiome that favor the acquisition of pathogenic bacteria. To that end, we
will leverage the highly translational rhesus macaque model to first identify age-associated changes in
immunological parameters, inflammatory markers and microbial community. Then, we will leverage a novel
rhesus macaque model established by our group that recapitulates the hallmarks of pulmonary MAC disease to
carry out experimental prospective studies to uncover age-mediated alterations in immune responses and lung
microbial communities that are associated with susceptibility to and development of chronic NTM pulmonary
disease. These studies will lead to novel insight into the pathogenesis of this chronic lung disease that causes
significant morbidity in the elderly and continues to increase in incidence and prevalence as the American
population ages. Identification of immune or microbiome correlates of protection or risk of disease could lead
directly to improvements in the clinical care of these patients and the prevention of this disease in the elderly.

Public health relevance
NARRATIVE Pulmonary nontuberculous mycobacterial disease is increasing in incidence and disproportionately affects the elderly. However, the mechanisms underlying increased vulnerability and disease severity in the elderly are unknown. Therefore, in this proposal we will identify these mechanisms by investigating age related changes in immunity and microbial communities in the lung using a translational nonhuman primate model.